GLYCEROL AND GASTRIC EMPTYING DURING EXERCISE

The primary purpose of this study is to evaluate the gastric emptying characteristics of glycerol (G) mixed with standard oral rehydration solution (ORS) (carbohydrate (CHO) (6-8%) and low concentrations of electrolytes (eg. NA+ 10 meg) during constant load submaximal exercise. A second purpose of the study is to evaluate the effects of G hydration on plasma volume (PV) both before and during exercise.